Translational Research Career Development: Overcoming Resistance to Radiotherapy

Head and neck cancer (HNC) is the sixth most common malignancy worldwide, diagnosed twice
as frequently in veterans. Radiation therapy (RT) is an important component of cancer
treatment; however, its efficacy is limited by radioresistance, with the cancer sometimes
returning within the treated area. Resistance to RT is, at least in part, mediated by adaptive
signaling events induced by treatment. However, we do not yet understand the pathways used
by cells to evade the cellular damage caused by RT. The long-term goal is to better understand,
and subsequently target, the mechanisms of resistance that cancer cells use to evade a
radiation-induced death. Combinatorial adaptive response therapy (CART) represents a novel
platform that allows for the rapid and systematic identification of treatment combinations that
overcome therapeutic resistance and result in synthetic lethality. CART takes advantage of
Reverse Phase Protein Microarray Analysis (RPPA), providing a high throughput, sensitive, and
quantitative approach to analyze differential protein expression to identify targets for
combinatorial therapy. The applicability of the CART approach to RT has not previously been
investigated. The central objective of this career development application is to develop myself
as an independent translational scientist with expertise in HNC, and to become a leader in the
field of translational oncology, with implementation of a CART approach to increase the efficacy
of RT in 3D culture and xenograft models. The rationale for the proposed research is rationally
combining newly identified systemic treatments, such as the glutaminase inhibitor, CB-839, with
RT will result in maximal efficacy while minimizing potential toxicities. Guided by strong
preliminary data implicating glutaminase as playing a role in adaptive resistance to RT, we will
pursue three specific aims: First (SA1), we will determine whether the combination of RT with a
glutaminase inhibitor (CB-839) results in decreased aerobic respiration and increased cell death
in 2D and 3D culture. To pursue this, upregulated aerobic respiration pathways, including those
catalyzed by glutaminase, will be selectively targeted alone or in combination with RT in 3D with
analysis of proliferation and apoptosis markers. Seahorse technology will be used to assess
aerobic respiration. Second (SA2), we will validate the efficacy of glutaminase inhibition by
testing it both alone and in combination with RT in preclinical heterotopic cell line and patient-
derived xenograft animal models. Finally (SA3), we will identify other novel HNC signaling
pathways that are significantly altered by RT using RPPA. For this aim, spheroids grown from
oral cavity tumor derived cell lines will be grown in 3D culture and subjected to non-lethal RT
doses with protein levels assessed by RPPA to identify candidate target proteins that are
differentially expressed with RT. This innovative approach uses a cutting-edge, high-throughput,
sensitive, and quantitative method (RPPA) to identify entirely novel therapeutic targets to be
used in combination with RT, at the protein level. The proposed research is significant because
it is testing a rationally selected treatment (CB-839) to increase the efficacy of RT. These
experiments will lay the groundwork for future clinical trials and are expected to identify
additional unknown, yet effective treatment combinations. In sum, this proposal outlines a
sophisticated, rational, and rapid approach to identifying and testing novel therapeutic targets
which would be of disproportionate benefit to veterans battling head and neck cancer.

Public health relevance
The proposed research and career development are relevant to the VA because head and neck cancer (HNC) is twice as common among veterans. Over 40,000 cancer cases are documented in the VA Central Cancer Registry each year with >1700 reported cases of HNC in 2007 alone (the most recent published Registry data). The cost of HNC treatment is >$50,000/pt, not accounting for potential treatment related complications. Tobacco and alcohol use remain among the strongest risk factors for the development of HNC. Among 2012 VA enrollees, over 20% (1.6 million patients) currently smoke and 70% identify as former smokers (versus 52% in the general population). There is also increased use of tobacco products in the Midwest, where the Cincinnati VA is located, and where 200 cases of HNC were diagnosed just last year. Therefore, the treatment of HNC in the VA population merits special consideration.